UCSD Collaborative Clinical Trials Unit

Abstract
The UCSD Collaborative Clinical Trials Unit (CTU) will bring together seven dynamic U.S. and International
Clinical Research Sites (CRSs) to facilitate innovative scientific synergies and leverage research collaborations
among investigators across our CTU and to contribute our scientific expertise and our diverse participant
populations to further the research priorities of the NIAID HIV/AIDS Adult Therapeutics Clinical Trials
Network and the HIV Prevention Clinical Trials Network. Our seven CRSs include: 1) the UCSD Antiviral
Research Center (AVRC) CRS; 2) the University of Southern California (USC) CRS; 3) the University of
Colorado Hospital (UCH) CRS; 4) the Houston AIDS Research Team (HART) CRS; 5) the University of
Miami CRS; 6) the Chennai Antiviral Research and Treatment (CART) CRS, and; 7) the Durban
International (DI) CRS. Each will bring considerable strength to achieve the future research goals of two of the
four NIAID networks. Our Collaborative CTU brings together a wealth of expertise, experience, and the high
quality performance required to conduct complex clinical trials in the following areas: HIV cure and functional
cure; viral persistence and latent reservoirs; broadly neutralizing antibody approaches to treatment and
prevention of HIV; pathogenesis and treatment of HIV-related inflammation, coinfections and comorbidities;
new antiretroviral drugs and novel formulations for HIV treatment and prevention; treatment and prevention of
tuberculosis (TB) in persons with mono- and HIV-coinfection; and biomedical, socio-behavioral, and
multipurpose technology strategies to prevent HIV transmission (including pre-exposure prophylaxis [PrEP],
HIV preventive vaccines, and molecular epidemiology to target “hot spots”) in populations at high risk for HIV
transmission. Our CTU provides access to and long-standing experience with community engagement in
underrepresented Hispanic/Latinx, Black/African American, African, and South Asian populations at risk for or
affected by HIV and its complications. Our U.S. CRSs span several of the highest burden regions for chronic
and new HIV infections in the southeast (Miami), south (Houston), southwest (Denver) and border regions (Los
Angeles, San Diego) identified in the U.S. “Plan to End the HIV Epidemic” campaign. Our international CRSs
include two of the highest burden regions globally for both HIV and TB, particularly drug-resistant TB (Southern
India and South Africa). We will address the following specific aims. Specific Aim 1: To provide outstanding,
innovative scientific contributions and leadership to the HIV/AIDS Adult Therapeutics Clinical Trials Network
and the HIV Prevention Clinical Trials Network. Specific Aim 2: To provide effective and efficient
administrative and financial resource management. Specific Aim 3: To engage and partner with diverse
communities affected by HIV to shape network scientific agendas and to recruit, enroll and retain a broad
diversity of research trial participants in network studies.

Public health relevance
Project Narrative The UCSD Collaborative Clinical Trials Unit (CTU) brings together seven dynamic Clinical Research Sites in the U.S., sub-Saharan Africa, and India, with a proven track record of significant research into the pathogenesis, treatment and prevention of HIV and its related complications and coinfections. Our proposed CTU has the expertise, experience, infrastructure, and access to geographically, racially and ethnically diverse participant populations living with or at risk for HIV to make valuable contributions to the research priorities of the NIAID clinical trials networks.